Development of a new class of EZH2 inhibitors in ERa-negative breast cancer

PROJECT SUMMARY/ABSTRACT
The histone methyltransferase (HMTase) EZH2 was proved to drive malignant phenotypes in various types
of cancer cells, including the estrogen receptor a-negative (ERa-) breast cancer. Therefore, selective small-
molecule inhibitors of EZH2 have been developed, all of which block its enzymatic activity. However,
accumulating evidence suggests that HMTase activity of EZH2, which is executed by the C-terminal
catalytic SET domain, may not represent an ideal target for anticancer drugs in certain situations. First,
multiple genetic studies suggest that the HMTase activity of EZH2 plays a tumor suppressive role in some types
of cancer. Second, EZH2 may promote tumorigenesis and cancer progression independent of its HMTase
competence. These scientific discoveries explain why some cancer cells that require EZH2 for their tumorgenicity
are insensitive to current EZH2 inhibitors and why secondary malignances were sometimes noted in patients
receiving tazemetostat, the first FDA-approved HMTase inhibitor of EZH2. All these clinical failures warrant the
development of new EZH2 inhibitors blocking the HMTase-independent oncogenic function of EZH2,
which may exhibit stronger antitumor potency, fewer side effects and wider clinical applications.
Recently, an N-terminal transactivation domain (TAD) was found to mediate the tumor-promoting effect of
EZH2 via gene activation instead of the HMTase activity. In ERa- breast cancer cells, we demonstrated that
malignant phenotypes such as proliferation and migration were unaffected upon tazemetostat treatment or
overexpression of the SET domain-deleted EZH2 but dramatically hindered when the TAD domain was truncated
or when the critical residues for the proper protein folding of the TAD domain were mutated. More importantly, a
group of genes that are essential for tumor migration was specifically activated by the functional TAD domain,
but not regulated by the SET domain. All these results suggest that this particular N-terminal TAD domain, rather
than the methyltransferase activity that current EZH2 inhibitors block, is required for the oncogenic function of
EZH2 in ERa- breast cancer cells. Based on these findings, we carried out a high-throughput screening for
chemicals that specifically interact with this TAD domain and a candidate compound was thus identified. The
lead compound directly binds to the TAD domain of EZH2, downregulates genes that promote cancer
cell migration and abrogates the aggressive phenotypes of ERa- breast cancer cells without interfering
with the methyltransferase activity of EZH2. Computer-aided structural analysis suggests that the critical
residues essential for the structure and functionality of the TAD domain may directly interact with this
prototype compound. Based on these preliminary data, we aim to develop a new class of EZH2 inhibitors
that target the N-terminal TAD domain and to further characterize their chemical and biological features
in the proposed study. Under the instructions of Co-Investigator Dr. Daohong Zhou and Collaborator Dr. Yaxia
Yuan, we will study the structure-activity relationship of our lead compound and further build its binding mode
with the TAD domain. We will also work with Consultant Dr. Stanton McHardy to design and synthesize the
analogs of the prototype compound. Finally, we will carry out the pharmacokinetics studies of the new EZH2
inhibitors with the assistance of Consultant Dr. Nicholas Clanton, evaluate their efficacy and elucidate the
mechanism of action of these compounds in ERa- breast cancer cells as well as in xenograft mouse models of
breast cancer in vivo by RNA-seq, ChIP-seq and proteomics analyses, which will be performed by Collaborator
Dr. Zhao Zhang.
Altogether, this study will yield first-in-class anticancer agents that target a different functional domain of
EZH2 to inhibit its oncogenic function in certain types of cancer cells that do not respond to current EZH2-
targeting drugs.

Public health relevance
PROJECT NARRATIVE In this study, we developed a first-in-class small-molecule inhibitor of EZH2, a histone methyltransferase that has been demonstrated by a myriad of studies to drive cancer development and progression. Instead of the C-terminal catalytic domain that current EZH2-targeting drugs interfere with, our compound binds to an N- terminal domain that is essential for the gene activation activity and methyltransferase-independent oncogenic effect of EZH2 in estrogen receptor a-negative (ERa-) breast cancer cells. Therefore, our prototype compound downregulated a group of genes that promote cancer cell migration and inhibited the malignant phenotypes of ERa- breast cancer cells that are insensitive to present EZH2 inhibitors. Results from our work will yield a new class of anticancer agents that specifically target a totally different functional domain of EZH2, which hold promise for broader clinical applications than current EZH2-targeted therapies.